Contribution of insertion sequence mediated tandem chromosomal amplification to bacterial heterogeneity

The long-term goal of the application is to understand how insertion sequences (IS) in bacterial
genomes create heterogeneous subpopulations by amplifying chromosomal segments. IS are short, mobile
DNA elements integrated into bacterial chromosomes and plasmids that encode a transpose flanked by
inverted terminal repeats (ITR). IS activity plays a major role in shaping prokaryotic genomes, where they can
destroy gene function through intragenic transposition, induce expression by juxtaposition of outward facing
promoter elements, remove/rearrange large segments of genomes by recombination events, and tandem
amplify DNA segments intervening between two IS elements. This proposal focuses on the latter process, as it
is the least well understood despite arguably being the most common and effective mechanism for generating
heterogeneous populations. Chromosomal tandem amplification catalyzed by IS elements generally occurs at
much higher frequencies in comparison to point mutations, amplifies intervening segments of DNA that can be
hundreds of kilobases long, and results in head-to-tail tandem copies of DNA segments separated by a third,
hybrid IS element. In genomes with high IS content, amplification thus generates tremendous heterogeneity
and transient single cell individuality that is revertible through subsequent recombination between the amplified
segments. Heterogeneity in bacterial populations helps ensure survival in the event of environmental stress
(including antibiotic treatment) by sampling a larger pool of cells with distinct phenotypes. The connection
between IS element activity, genome amplification, and heterogeneity will be explored in this proposal using a
model system of Escherichia coli B with the element IS1. In the first aim, how genomic IS1 element distribution
impacts frequency of amplification and the requirements for amplification will explored. In the second aim,
genetic and environmental factors will be identified using a Tn-seq assay that has been developed to be
specific for defined IS1-flanked chromosomal amplification events. In the third aim, the contribution of IS1 to
creating distinct lipopolysaccharide compositions and gene expression profiles at the single cell level will be
explored using a paired IS1-less strain. By understanding IS1-induced heterogeneity in a model bacterial
strain, the project will help formulate rationale strategies to mitigate the impact of heterogeneity on
antimicrobial bacterial resistance.

Public health relevance
Insertion sequences are small, mobile DNA elements residing in many bacterial genomes whose activation leads to subpopulations with amplified segments of the chromosome. The increased gene copy number creates heterogeneous cells with distinct phenotypes which improves odds of surviving environmental challenges, including nutrient stress and exposure to antibiotics. This project aims to understand host bacterial factors and environmental conditions that regulate insertion sequence activation and the generation of cell individuality.